STRUCTURE OF TOXIC POLYPEPTIDES FROM SEA ANEMONES

The goals of this research are to understand the molecular basis of the interactions of several neurotoxic polypeptides from sea anemones by first elucidating their-dimensional structure in solution by state-of- the-art NMR and related techniques (ESR spin labeling, CIDNP) The combined results of these approaches allow us to define both the average and dynamic structures of, e.g., tenebrosins-A, -B, and -C from the Australian sea anemone. The experimental approaches will involve collaborative molecular biological approaches as well, allowing specific isotopic labeling for higher order (3-D, 4-D) NMR studies. Following a 6-month visit, two annual 3-month visits are planned with ESR an CIDNP studies at Ohio State in the interim.